Interplay between the Endocrine and Innate Systems of Drosphila

Project Summary/Abstract
Innate immunity is an ancient defense response that evolved with the earliest metazoan creatures, and is
the first line of defense against microbial infection. These responses rely on the recognition of microbes by
germline-encoded receptors, and drive the production of numerous chemical, biological, and cellular defense
responses. In the face of constant microbial assault, innate immunity is essential for the survival of nearly all
multicellular organisms. On the other hand, over-exuberant or inappropriate innate immune responses are the
underlying cause of morbidity and mortality associated with many infectious and autoimmune diseases. The
endocrine system, through steroids as well as sex hormones and vitamin D, has profound pro- or anti-
inflammatory effects on the innate immune response. This crosstalk between the innate immune and endocrine
systems is found throughout the animal kingdom, and likely evolved with some of the earliest animals. This
proposal uses the fruit fly Drosophila melanogaster as a model for the study of these interactions. Flies offer
many advantages for these studies, including experimental tractability with arguably the most robust genetic
system for in vivo studies, extensive knowledge of steroid hormone regulatory networks, and an innate immune
system without the complexity of the adaptive immune response. Furthermore, many aspects of the innate
immune responses are highly conserved with mammals, and discoveries made in flies can be translated into
paradigm shifting findings in mammals. Particularly relevant for this proposal are the conserved NF-κB
signaling pathways, which drive the immediate response to infection, and the modulation of these signaling
pathways by steroid hormones.
A thorough mechanistic analysis of how the innate immune response is regulated by steroid hormones in
the Drosophila model system will provide a deeper understanding of these ancient regulatory interactions, and
are likely to identify new avenues for manipulating these interactions in vector insects and/or mammals.
Preliminary data demonstrate that the insect steroid hormone 20-hydroxyecdysone has a profound enhancing
effect on NF-κB dependent innate immune responses, through regulating the expression of the bacterial
sensing receptor PGRP-LC. This regulatory network enables the ecdysone to prime the innate immune
response, creating more effective immune defenses in times of stress. The experiments outlined in Aim 1 are
designed to elucidate the molecular mechanisms underlying this hormonal control of immunity, while Aim 2 will
probe the molecular and cellular mechanisms by which the steroid ecdysone responds to stress and primes
immune defenses. In Aim 3, we will probe the role steroid-regulated immune signaling in driving
developmentally programmed autophagic cell death and tissue degradation. All three of these Aims build upon,
and extend in exciting new directions, the findings from our previous cycle of support for this grant.

Public health relevance
Project Narrative Innate immunity plays a critical role in nearly all infectious and autoimmune diseases, and is very similar in nearly all animals. Steroid hormone signaling is also very similar in throughout the animal kingdom. This project will examine innate immune system of the fruit fly Drosophila melanogaster and how it is modulated by steroid hormones \. This research may have a direct and profound impact on continuing efforts to modulate the immune response in mosquitoes, in order to reduce the transmission of vector-borne diseases such as malaria, Zika Virus or West Nile Virus. In addition, the discoveries from this research may have direct relevance to similar innate immune and hormone signaling pathways in humans.